PLASTICITY OF CORTICAL ENSEMBLE CONNECTIVITY IN VISUAL LEARNING

Vision is a critical sensory modality that we depend on to navigate through the world and understand our
surroundings. Disorders of the visual system lead to severe interpersonal deficits and to economic
immiseration. Although much progress has been made describing the cellular basis of visual perception,
little is known about the connectivity of brain circuits that process visual information, and even less is
known about how this connectivity changes over time. I propose to leverage cutting-edge robotic and
optical technologies to clarify how neuronal ensembles (coactive groups of cells) are connected in the
primary visual cortex (V1), the neocortical region where visual perception arises. Ensembles in V1 exhibit
activity patterns with reproducible spatial and temporal structures which define the functional vocabulary
of cortical microcircuits. It has been recently shown that the activation of ensembles is necessary and
sufficient for visual perception. The Hebbian hypothesis suggests that neurons that are repeatedly
coactive over time (ensembles) are likely to be more strongly synaptically connected to one another than
to neurons outside of the ensemble. I will develop a high-throughput tool to test this Hebbian hypothesis
of preferential synaptic connectivity within ensembles using robotic electrophysiology and holographic
optogenetic stimulation (Aim 1). I will then describe the functional and structural changes of cortical
microcircuits during visual learning using chronic two-photon calcium imaging of neurons in the mouse
visual cortex, in relation to the Hebbian hypothesis of synaptic plasticity and learning (Aim 2). Successful
completion the current project will establish a structural link between ensemble activity and the activity of
the brain during visual learning, yielding inroads towards a more complete understanding of visual
processing, a prerequisite to addressing the dearth of effective treatment options for blindness.

Public health relevance
Project Narrative Vision loss is a common disorder that causes severe interpersonal deficits and economic immiseration in humans. Efforts to treat this disorder with prosthetics or circuit intervention are still largely ineffective due to a lack of tools to understand the basic circuit structure underlying visual perception. The proposed project will seek to demonstrate the first link between patterns of activity in the visual cortex and the synaptic interconnectivity of those neurons using cutting-edge robotic and optical tools, pointing the way toward novel therapies for treating diseases of the visual system.